Germination and Pathogenesis of Cryptococcus Spores

ABSTRACT: In the United States gross mortality from invasive fungal disease is approximately 50%. People
with AIDS, chemotherapy patients, and transplant recipients are at highest risk of acquiring life-threatening
infections, but many fungi also cause disease in apparently healthy individuals. The environmental yeast
Cryptococcus epitomizes this trend. Like many fungi, infection with Cryptococcus occurs when it is inhaled into
the lung from which it can disseminate to the central nervous system (CNS) and cause disease. Once in the
CNS Cryptococcus causes fungal meningoencephalitis that is fatal ~25% of the time, even with state-of-the-art
treatment. This high incidence of mortality is consistent with other invasive fungal diseases and indicative of
the dire need for improved therapeutics. To develop new strategies for combating invasive fungal pathogens, it
is imperative that we gain a better understanding of the fundamental biology of fungal pathogens. Our long-
term research goal is to understand the properties of fungal infectious particles and how they cause disease. In
Cryptococcus, both yeast and spores are likely infectious particles of humans, but studies of the pathogenic
potential of spores were historically hampered by technical limitations. Recently, however, we purified spores
to homogeneity in numbers sufficient for comprehensive biochemical, molecular, and virulence studies. Using
this novel reagent, we discovered that spores can cause disease in a mouse model, providing the first
evidence that spores can act as infectious particles in mammalian cryptococcosis. The objective of this
proposed project is to investigate for the first time the key processes by which fungal spores transition from
quiescent cells into vegetatively growing yeast (germinate) and infect the mammalian lung. Our central
hypothesis is that by determining the cellular and molecular mechanisms governing spore germination and
lung invasion, we will identify key events in spore-mediated infections that can be targeted for inhibition. To test
this hypothesis, we will carry out two Specific Aims: 1) identify the cellular and molecular events that occur
during germination of spores and 2) determine the mechanism(s) by which spores cross the epithelium to
colonize the lung. We will combine molecular and classical genetics, gene expression data, protein
composition data, and quantitative high-resolution germination assays to parse the germination process into
discrete events. At the same time we will use in vitro tissue culture models, a new organotypic microlung
model, and a mouse intranasal model of infection to determine how spores colonize the lung. These innovative
experiments will result in an in-depth map of germination pathways and insights into how spores invade the
host. Understanding pathways and processes associated with the two pivotal events that occur during spore-
mediated disease (germination and infection) makes significant contributions to the long-term objective of this
work to identify new and diverse molecular, cellular, and systemic targets that can be exploited for novel
antifungal therapeutic strategies to prevent and/or treat cryptococcosis and other fatal human fungal diseases.

Public health relevance
PROJECT NARRATIVE Fungi, including the spore-forming environmental yeast Cryptococcus, are emerging pathogens that cause life- threatening diseases in humans. The proposed research is relevant to public health because determining the fundamental biology of Cryptococcus spores and how they infect the mammalian lung will provide information necessary to understand how fungal pathogens infect people and cause fatal diseases. This project is relevant to the missions of the NIH and NIAID because it proposes basic research that will ultimately lead to new strategies to prevent and/or treat severe fungal disease, which will enhance human health and reduce illness, particularly among immunocompromised patients.